Condensates in Leukemias

PROJECT SUMMARY - PROJECT 2
Acute leukemias are the most common pediatric malignancy and are broadly defined by their cell lineage into
acute lymphoblastic leukemia (ALL) or acute myeloid leukemia (AML). Regardless of lineage, pediatric
leukemias are commonly defined by fusion oncoproteins (FOs) that involve transcription factors, epigenetic
regulators and tyrosine kinases, many of which are associated with chemotherapy failure and disease relapse.
A deeper understanding of the molecular mechanisms that drive aberrant transcriptional activity in FO-driven
leukemias has the potential to nominate new therapeutic options for these high-risk leukemias. Our previous
efforts focused on NUP98 FOs, a subtype of high-risk pediatric AML, demonstrated that these FOs form
biomolecular condensates mediated by intrinsically disordered regions (IDRs) within NUP98 and associations
between non-IDR regions and DNA. Further we showed that disrupting this process abrogates hematopoietic
cell transformation. While these studies established a causal link between IDRs and other structural features,
condensate formation and the potential for hematopoietic cell transformation, the broader importance of FO-
mediated condensate formation in cellular transformation, and its relevance to therapeutic targeting across
the landscape of pediatric leukemia FOs, is poorly understood. Importantly, our preliminary analyses using a
machine learning model trained on physicochemical features of known condensate forming proteins predict
that 73% of ALL FOs and 86% of AML FOs will form condensates in cells. These collective preliminary data
provide the scientific premise to dissect the mechanistic links between condensate formation and
transcriptional deregulation in pediatric acute leukemias. We hypothesize that condensate formation driven
by folded domains and IDRs in FOs and associated partner proteins is a central feature of acute leukemia
FOs that leads to deregulated transcriptional networks and potential therapeutic vulnerabilities. We will test
our hypothesis with the following specific aims using a combination of genetic tools, biochemical strategies
and functional genomics. Aim 1 will dissect the impact of FO structural features on transforming potential and
chromatin landscapes. Aim 2 will establish the contributions of FO interacting proteins to cellular
transformation and condensate formation. Aim 3 will decipher the direct impact of FO IDRs on target gene
expression. Not only will the proposed studies elucidate the mechanistic underpinnings of altered
transcriptional activity resulting from condensate formation, but they will also nominate potential therapeutic
vulnerabilities for pediatric leukemias.

Public health relevance
PROJECT NARRATIVE – PROJECT 2 Pediatric leukemias are a heterogenous group of hematopoietic neoplasms largely driven by the expression of fusion oncoproteins (FOs) that leads to deregulation of transcriptional networks. Although recent studies by our groups and others have shown that FOs involving NUP98, which are common in pediatric AML, form molecular condensates and that condensate formation is associated with transforming potential, it is not clear if this is a common feature of leukemia FOs. The successful completion of these studies, which will deeply interrogate a range of leukemia FOs, will provide mechanistic insights into the interplay of molecular condensates and gene regulation and will nominate new targets for therapeutic interventions for pediatric leukemias.